IGF::OT::IGF WOODS & POOLE ECONOMICS INC:1107927 - Obtaining Annual Population Estimates for Counties and Census Tracts Based on the Counts Produced by the US Census Bureau

Obtaining Annual Population Estimates for Counties and Census Tracts Based on the Counts Produced by the US Census Bureau